AI-assisted multimodal digital remote screening for bulbar ALS to support timely referral to SLP care

PROJECT SUMMARY
The overall aim of this research is to develop novel clinical predictive algorithms (CPAs) to improve the
management of ALS via detection of early signs of bulbar disease and prognostication of the risk of
clinically significant bulbar indicators. Currently, the onset of bulbar symptoms is not tracked outside of the
clinic, which leads to delayed detection of bulbar abnormalities, missing of the critical points in ALS
progression, and delayed referral to speech language pathology (SLP) services. There is a critical need to
develop a tool for automatic remote assessment to achieve these clinical goals. This research will follow
the phased CPA development framework – focusing on its development phase - in service of building
robust and valid CPAs for real-world clinical use. In this project, we will address three specific aims (SAs).
In SA1, we will examine the effect of repeated test administration (practice) on key features of bulbar
dysfunction, such as alterations in speech timing in connected speech. We hypothesize that there will be
a practice effect on repeated speech stimuli, but it will level off with time. In SA2, we will develop and
internally validate a CPA for screening early bulbar dysfunction. We expect a strong classification
performance on the CPA based on multimodal (audio + video) feature set. In SA3, we will develop and
internally validate a CPA for predicting the risk of decline on established indicators of bulbar disease
progression (speech and swallowing loss) at 6-, 9- and 12-months post-baseline. We anticipate a strong
ability of the risk CPA to predict bulbar decline.
We will recruit 100 patients with ALS and early stages of bulbar decline and 100 demographically
matched healthy controls (HCs). Oro-motor and speech data will be collected using multimodal, web-based
platform, which will also be used to generate acoustic and kinematic feature set from audio and video data.
The data will be collected longitudinally. We will assess patients and HCs for 5 months, with additional
clinical follow-up for patients at 6-, 9-, and 12-months. To address SA1, we will use piecewise mixed-
effects models (PMEs) for quantifying practice effects and for identifying potential plateaus. To address
SA2, we will use a supervised machine learning (ML) classification model that will be trained to
automatically distinguish patients in early stages of ALS from HC. To address SA3, we will use a joint
model, which combines a longitudinal model and a survival model, to estimate the probabilistic risk of
future clinically significant bulbar change at the three horizons post-baseline.
This effort will yield robust, valid, and meaningful CPAs that will be ready for further evaluation
(extremal validation) in the context of multisite clinical trials. This work is poised to provide a critical
advancement in the clinical management of ALS patients via remote automatic assessment and supply
additional valuable information that may be used for surrogate endpoint development for clinical trials.

Public health relevance
PROJECT NARRATIVE The current project focuses on the development of a remote automatic screener to detect bulbar dysfunction in patients with amyotrophic lateral sclerosis (ALS) and predict the risk of loss of speech and swallowing function longitudinally. To achieve our objective, we will develop and validate clinical algorithms that can be used for remote assessment. These tools will provide critical advancements in managing bulbar symptoms in ALS, patient care, and patient autonomy.